Integration of S-adenosylmethionine Metabolism with Epigenetics and Cell Cycle

DESCRIPTION (provided by applicant): The principal methyl-donor S-adenosylmethionine (SAM) is synthesized from methionine and ATP, and participates in more cellular reactions than any other molecule except for ATP. As the co-factor for all chromatin methylation events, SAM is critical for the maintenance and transmission of epigenetic information. It is reasonable to predict a cellular system that monitors intracellular SAM concentrations and prevents initiation of cell division when SAM levels are too low to ensure faithful duplication of chromatin methylation during S-phase. This concept is reminiscent of the cell cycle checkpoint idea and we thus refer to it as the SAM-checkpoint. For my thesis work I propose to generate a molecular understanding for how cells monitor intracellular SAM concentrations and how this information is transmitted to the cell cycle machinery to induce the SAM-checkpoint. I will examine how cells monitor intracellular SAM levels and how DNA replication is blocked when SAM levels fall below a critical threshold concentration. My hypothesis is that SAM sensing is linked to translational control of a small number of sensory proteins. I suggest that select mRNAs of these sensory proteins are regulated at the level of mRNA cap methylation. The mechanism of this regulation will be addressed via purification of N7 methyl-capped mRNAs from cells experiencing SAM limitation. Furthermore, models have been developed that will allow me to address fundamental questions about epigenetic stability and the effect of dietary limitations on epigenetics. To assess epigenetic stability I will use yeast reporter strains modified to evade the SAM-checkpoint and monitor histone methylation of yeast cells in SAM limiting conditions. Similar experiments using inducible knock-down of methionine adenosyltransferase, the enzyme responsible for SAM synthesis, will address related questions in the mammalian system. For my thesis work I propose to generate a molecular understanding for how cells monitor intracellular SAM concentrations and how this information is transmitted to the cell cycle machinery to induce the SAM-checkpoint. This research may generate a paradigm for metabolite-regulated cell cycle checkpoints and will approach fundamental questions about epigenetics. My proposed studies will generate a first insight into how metabolic pathways are connected to cell function at the molecular level. My proposal specifically addresses the interaction of metabolic pathways and stability of epigenetic information. Results may have important consequences for our understanding of dietary factors and supplements such as SAMe, folates, or vitamin B12. My thesis proposal will only begin to address nutrient imbalance as a factor of epigenetic changes. However, I will develop tools to allow others to expand research on the interaction between nutrients and epigenetics.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cell cycle progression relies on availability of key metabolites. When cells experience insufficient levels of metabolites the cell cycle is halted, which can result in cell death. To date, it is mostly unknown how metabolites are sensed and how information assessing metabolite shortages directly transmit to cell cycle machinery and trigger cell cycle arrest. Cancer cells show an altered metabolism and are addicted to certain metabolic pathways to sustain their uncontrolled growth. Thus, a molecular understanding of the integration of cell cycle progression and metabolism are critical for the identification of novel cancer therapeutics. __SpecificAimsTextDelimiter__ Specific Aims Metabolism and cell division are two fundamental components of living cells, however, our understanding of how metabolite availability is integrated with cell cycle progression is extremely limited. Metabolic pathways in cells generate energy, structural building blocks, signaling molecules, and co-factors for enzymatic reactions. All cell functions rely on these molecules provided by the metabolic network. Therefore, control mechanisms or "checkpoints" need to be in place to monitor availability of metabolites. Although both metabolism and the cell cycle are intensely studied, the molecular connection between these cellular processes is still undefined. The study of such molecular links will not only contribute to our understanding of the molecular biology of cells but also presents a great opportunity to identify novel drug targets for future cancer therapeutics. Of particular interest is the principle methyl donor S-adenosylmethionine (SAM), a key cellular metabolite with an undefined link to cell cycle control. SAM is synthesized in all organisms from methionine and ATP, and is critical for the maintenance and transmission of epigenetic information. Therefore, it is logical to predict a cellular control mechanism that monitors SAM concentrations and prevents cell division when insufficient SAM levels may result in unsuccessful duplication of chromatin methylation during S-phase. Similar to the concept of a cell cycle checkpoint, we thus refer to this control mechanism as the SAM-checkpoint. Consistent with this hypothesis, work in my laboratory has shown both in yeast and mammalian systems that SAM limitation triggers loss of pre-replication complexes from chromatin and prevents entry into S-phase. In contrast to normal cells, the vast majority of cancer cells experience the metabolic phenomenon known as "methionine dependency." When methionine in growth media is replaced by its immediate metabolic precursor, homocysteine, cancer cells are no longer able to proliferate. We have uncovered the SAM-checkpoint as the molecular pathway behind this phenomenon and our studies demonstrate that homocysteine media leads to SAM depletion and activation of the SAM-checkpoint. Following SAM-checkpoint induction, cancer cells undergo cell cycle arrest and eventually apoptosis, thereby defining the methionine dependency of cancer as a manifestation of a cellular hypersensitivity to SAM limitation. Both our previous findings and the biochemical tools we have developed provide an excellent platform to define the molecular mechanism of a novel cell cycle checkpoint (Aim 1) and to identify global metabolic changes and altered gene expression induced by SAM limitation (Aim 2), which may help to uncover novel therapeutic drug targets that exploit a unique metabolic requirement of cancer. The significance of this proposal is that it will (i) identify the molecular mechanism integrating a metabolic pathway with cell cycle control, (ii) characterize molecular events required for communication between metabolism and pre-replication complex stability, and (iii) characterize global metabolic and gene expression effects resulting from SAM limitation. These results may lead to new approaches for selective killing of cancer cells. The innovation of this proposal is the description of molecular pathways that define a metabolite-controlled cell cycle checkpoint important for the preservation of epigenetic information. This is a significant conceptual advance similar to DNA-damage checkpoints that act at the level of genetic stability. Additionally, our work will unmask novel drug targets for cancer specific metabolic therapies. The proposal has the following two specific aims: Aim 1: Mechanism of cell cycle checkpoint induction by SAM limitation: We will identify how SAM concentrations are sensed, how this information is communicated to cell cycle machinery, and what the mechanisms of cell cycle arrest are during SAM limitation by investigating SAM regulated RNA translation. Aim 2: Global characterization of Metabolite and Transcription Profiles important for SAM regulated cell cycle checkpoint and cancer: We will determine the global metabolic changes and alterations in gene expression induced by SAM limitation, and identify those changes that are specific for cancer cells.